HYPOGLYCEMIA COUNTERREGULATION IN DIABETES

We examined the ability of an equal increase in plasma glucose to inhibit GP and to stimulate glucose metabolism in DM2 patients. SRIF was infused with basal replacements of glucoregulatory hormones and plasma glucose was maintained either at 90 or 180 mg/dl. Overnight low dose insulin was used to normalize plasma glucose levels in DM2 prior to study. With identical and constant plasma insulin, glucagon, and GH levels, a doubling of the plasma glucose (to abour 180 mg/dl) inhibited GP by 41% and stimulated peripheral glucose uptake by 71% in nondiabetic subjects (n=7). However, the same increment in plasma glucose failed to lower GP, and less effectively stimulated glucose uptake (by only 49%) in patients with DM2 (n=9). The rate of glucose infusion required to maintain the same hyperglycemic plateau was 57% lower in DM2 than in nondiabetics. Despite diminished rates of total glucose uptake during hyperglycemia, the ability of glucose per se (at basal insulin) to stimulate whole body glycogen synthesis (glucose uptake minus glycolysis) was comparable in DM2 and in nondiabetics. To examine the mechanisms responsible for the lack of inhibition of GP by hyperglycemia in DM2 we also assessed the rates of total glucose output (TGO), i.e., flux through glucose -6-phosphatase, and the rate of glucose cycling ([3H-2]- and [3H-6]- glucose infusions) in a subgroup of the study subjects. In the nondiabetic group hyperglycemia inhibited TGO by 35%, while glucose cycling did not change significantly. In DM2, neither TGO or glucose cycling were affected by hyperglycemia. The lack of increase in glucose cycling in the face of a doubling in circulating glucose concentrations suggested that hyperglycemia at basal insulin inhibits glucose -6-phosphatase activity in vivo. Conversely, the lack of increase in glucose cycling in the presence of hyperglycemia and unchanged TGO suggest that the increase in the plasma glucose concentration failed to enhance the flux through glucokinase in DM2. In summary, both lack of inhibition of GP and diminished stimulation of glucose uptake contribute to impaired glucose effectiveness in DM2. The abilities of glucose at basal insulin to increase the flux through glucokinase and to inhibit the flux through glucose -6-phosphatase are impaired in DM2. Conversely, glycogen synthesis is exquisitely sensitive to changes in plasma glucose in patients with DM2.